CHOLINERGIC/SEROTONERGIC BALANCE IN REGULATION OF SLEEP

To test the hypothesis that cholinergic REM induction with pilocarpine will be inversely related to serotonergic inhibition of REM sleep with ipsapirone within the same subject.